TP-R: a novel mediator of obesity-linked insulin resistance in humans

Thromboxane A2 (TXA2), a pro-inflammatory lipid mediator derived from arachidonic acid, exerts
its biological effects via thromboxane-prostanoid receptor (TP-R). However, it is currently
unknown whether TP-R can modulate metabolic pathways. Although the adipocytes are mainly
involved in the storage of excess triglycerides, emerging evidence suggests that they have an
important role in amino acid (AA) metabolism, in particular branched chain AAs; of note, elevated
plasma levels of branched chain AAs is strongly associated with insulin resistance. However, the
role of adipose tissue (AT) in the metabolism of other essential AAs is still unclear. The preliminary
data provide evidence that mice lacking TP-R (TP-R-/- mice) grow lean when exposed to a high
caloric diet. Moreover, a striking increase in markers of histidine catabolism in the AT of TP-R-/-
mice was noted. Further, these mice showed a reduction in AT inflammation and improvement in
insulin sensitivity and glucose homeostasis on a high fat diet. Therefore, the overall hypothesis is
that TP-R plays an important role in mediating obesity-related inflammation and insulin
resistance via altered His and/or glucose metabolism in adipose tissue. Clinical,
biochemical, and molecular approaches will be employed to determine the potential of TP-R as a
therapeutic target in obesity-related insulin resistance and investigate the mechanisms by
which TP-R blockade improves insulin resistance, inflammation, and histidine and glucose
metabolism in AT. In Specific Aim 1, we will conduct studies subcutaneous and visceral AT and
PBMCs collected from lean/overweight insulin sensitive and obese insulin resistant subjects.
We will compare TP-R expression in AT and PBMCs between lean/overweight insulin
sensitive and obese insulin resistant subjects and determine the potential of TP-R as a target
for therapy against obesity-linked insulin resistance in humans. In addition, detailed
mechanistic studies will be conducted in cultured AT explants, primary adipocytes and
human adipocyte cell-line to determine mechanisms by which TP-R promotes insulin
resistance. In Specific Aim 2, we will correlate visceral and subcutaneous AT TP-R
expression with markers of inflammation. In addition, we will determine mechanisms by
which TP-R promotes inflammatory response in AT explants, adipocyte cell-line, and PBMCs.
In Specific Aim 3, we will correlate visceral and subcutaneous AT TP-R with histidine
transporters in AT, in particular Slc15a4. Furthermore, we will perform studies in cultured
explants and cells to determine the role and mechanism of TP-R in modulating histidine and/or
glucose metabolism. The findings will be relevant to uncover the role of TP-R in metabolic
control and develop novel therapeutic strategies to manage hyperglycemia in obesity and type
2 diabetes.

Public health relevance
Obesity increases the risk of developing type 2 diabetes. Over 35 percent of veterans are obese and many veterans are morbidly obese. Thromboxanes are fatty acid metabolites which are known to mediate inflammation by binding with a protein called thromboxane-prostanoid receptor (TP-R). Our preclinical studies show that mice lacking TP-R gene gained less body weight, and showed improvements in glucose handling on a high fat diet. Our data also show that markers of amino acid metabolism, in particular, histidine metabolism, are dramatically increased in the adipose tissue. Therefore, we hypothesize that blocking TP-R activation may be helpful to promote histidine metabolism in adipose tissue which, in turn, can improve systemic glucose homeostasis in obesity. This proposal involves collaboration between Dr. Viswanathan, a basic scientist and Dr. Desouza, a clinical investigator. The proposed studies will lead to development of a novel drugs to manage obesity and/or type 2 diabetes in VA and general population.